Mechanistic Interrogation of Long Non-coding RNAs using Photocatalytic Proximity Labeling and CRISPR Phenotypic Profiling

Project Abstract
Over 90% of the human genome is transcribed into RNA, yet only ~1-2% represents protein-coding genes. Long
non-coding RNAs (lncRNAs) make up the majority of these transcripts and have vital roles in chromatin
organization, gene expression control, and metabolic regulation. Despite their abundance, our understanding of
lncRNA function and regulation significantly lags behind that of proteins, leaving the vast majority of lncRNAs
understudied or completely uncharacterized. This knowledge gap not only limits our understanding of basic
cellular processes but also hinders our ability to therapeutically target RNA or design synthetic transcripts as
biomedicines. Significant technical challenges underlie this gap surrounding lncRNAs, and few tools exist for
directly studying their function. To address these problems, this proposal aims to develop and apply experimental
platforms to mechanistically understand lncRNA function by both mapping their interactomes in cellulo and
elucidating their structure-function relationships through CRISPR-based perturbation profiling. In Aim 1 I will
apply technology I have developed in my postdoc to directly map native lncRNA interactions with protein, RNA
and genomic sites using in situ hybridization photoproximity labeling. The platform will be first validated using
known lncRNAs and subsequently applied to probe uncharacterized oncogenic transcripts in breast cancer, as
well as mapping the cellular interactions of prime editing guide RNAs for genetic engineering. In Aim 2 I will
develop and apply CRISPR-based techniques for mechanistic profiling and functional discovery of lncRNAs
using phenotypic screening. This aim will directly explore the phenotypic contributions of oncogenic lncRNAs
with unknown mechanisms by measuring their influence on global expression levels using Perturb-seq single-
cell knockout. Additionally, pooled CRISPR knockout screening will be employed to identify novel lncRNAs that
influence cell migration and metastasis in vivo. Lastly, a novel approach combining minimization by iterative size-
exclusion and recombination (MISER) with CRISPR mutational scanning will classify key domains and residues
in lncRNAs, providing fundamental insights into their structural biochemistry and regulatory roles in cell behavior.
Overall, this research proposal aims to bridge the gap in our understanding of lncRNAs by developing innovative
tools for mapping interactomes and discovering functional mechanisms. Directly applying these tools will enable
systematic testing of hypotheses regarding lncRNA function and provide fundamental measurements of their
effects on global gene expression, cell growth, and motility. If successful, these platforms will deepen our
understanding of RNA function and significantly expand our capabilities for both targeting pathologic RNAs with
small molecules as well as enable future design and engineering of therapeutic transcripts and RNA biologics.

Public health relevance
Project Narrative The majority (>90%) of the human genome consists of non-coding regions that do not directly yield proteins but are transcribed into RNA. Long non-coding RNAs (lncRNAs) represent a large class of these molecules (>170,000) that can have crucial regulatory functions in a variety of biological processes, yet the vast majority of lncRNAs remain completely uncharacterized. This proposal seeks to develop and apply photocatalytic proximity labeling technology and CRISPR-based phenotypic profiling to better understand the mechanisms of lncRNAs, in turn answering fundamental questions surrounding these transcripts in normal and disease biology and es- tablishing novel modalities in precision medicine.